Exposure pathways and mental health impact of PFAS-contaminated biosolids

PROJECT ABSTRACT
Per- and polyfluoroalkyl substances (PFAS) are persistent “forever chemicals” that make paper and other
products stain resistant, but also contaminate water and food and are detectable in almost every individual in
the US. An understudied exposure source is farmland throughout the rural US where PFAS-contaminated
biosolids are applied as fertilizer. Incomplete information about non-water exposure pathways leaves affected
communities, many of whom are dependent on local agriculture and game for work and food, uncertain how to
minimize exposure. PFAS-contaminated biosolids threaten the livelihoods and food sources of these agrarian
communities, as plant and wildlife exposure to PFAS from biosolids makes selling and consuming local
produce, animal products, or wild fish and game no longer safe. Maine has the unique capability to investigate
these issues because of 2021 state legislation that mandated PFAS testing on land with prior or ongoing
application of biosolids. One sentinel site, the town of Fairfield, was found to have PFAS up to the 1000’s
mg/kg in soil and 30,000’s ng/L in drinking water from private wells—far above local and national health
advisories (EPA’s drinking water advisory is 0.004 ng/L for PFOA). As of now, there are enough impacted
individuals across central Maine [319 wells with PFAS above the Maine health advisory (sum of 6 legacy PFAS
≥ 20 ng/L)] to establish a cohort to guide other communities affected by biosolids across the US. In this study,
our objective is to recruit 300 adults at risk of exposure to PFAS from biosolids to (1) quantify PFAS
concentrations in serum, (2) evaluate water and non-water exposure pathways, and (3) characterize
associations of PFAS with anxiety and perceptions of health risk and stigmatization. The time-sensitive R21
mechanism will allow us to obtain an immediate assessment of serum PFAS levels, which is critical because
some affected individuals learned of the contamination and had a water filter installed up to 2 years ago. PFAS
have long half-lives (3-8 years depending on the compound), and serum measures up to 2 years post-clean
water will be consistent with other community contamination cohorts. To minimize recall bias, it is also
imperative before more time elapses to assess water intake, other potential exposure pathways, and anxiety
and perceptions of health risk/stigmatization before and after knowledge of the contamination. Our
interdisciplinary team has expertise in environmental epidemiology, clinical care of patients with PFAS
exposure, and social psychology. We will partner with the community through a community advisory board,
context-rich report back of individual results, and presentation of aggregated study results at town hall
meetings. We will be the first to our knowledge to establish a cohort with PFAS exposure from biosolids, and
our results will help to generate exposure mitigation advice and interventions to build resilience among
individuals living in communities impacted by PFAS-contaminated biosolids.

Public health relevance
PROJECT NARRATIVE PFAS-contaminated biosolids are applied as fertilizer on farmland across the US, but incomplete information about non-water exposure pathways leaves affected communities uncertain how to minimize exposure and threatens local agricultural enterprises due to plant and wildlife exposure to PFAS from biosolids. In this project, we will work with the central Maine community to be the first to our knowledge to establish a cohort with PFAS exposure from biosolids, evaluate potential exposure pathways, and characterize associations with anxiety and perceptions of health risk and stigmatization. Results from our study will help to inform exposure mitigation advice and interventions to build resilience among individuals living in communities across the US affected by PFAS-contaminated biosolids.